INTERVENTIONS TO REDUCE DIABETES RISK IN JAPANESE AMERICANS

To demonstrate that endurance type physical activity and reduction in dietary animal fat by Japanese Americans with impaired glucose tolerance (IGT) will result in a reduction of risk factors associated with progression to NIDDM. 80 subjects with IGT baseline and follow-up body composition, body fat distribution, insulin sensitivity and beta cell function, as well as selected lipid and lipoprotein measurements associated with the insulin resistance syndrome.